Shared Resource Management

PROJECT SUMMARY/ABSTRACT
Management of Shared Resource Facilities (SRF) fosters the execution of strategic science goals of the
Markey Cancer Center (MCC). Since their inception, MCC SRFs have benefitted from strong and experienced
leadership, significant investment and support from MCC and the University of Kentucky, utilization of unique
processes to facilitate effective delivery and coordination of services, and governance by evaluation and
oversight from advisory committees and the MCC Director’s Council. The aims of SRF Management are to: 1)
Promote state-of-the-art technology, methodologic and content expertise to foster MCC scientific strategies
across three Research Programs; 2) Conduct rigorous monitoring and evaluation processes and support
financial health for stability of SRF infrastructure, and 3) Facilitate robust and stable access to MCC shared
resources through innovative initiatives. The SRFs received improved ratings from NCI’s 2018 site visit and
have exhibited continued growth in breadth of services, depth of skills and service provision aligned with the
research direction of MCC’s programs. In addition, SRF management was guided by a culture of integrated
and collaborative relationships with MCC researchers with formalized processes for hand-offs among SRFs
facilitating enhanced support and the bi-directional continuum of MCC research from basic science to clinic
and into the community. MCC is supported by seven established SRFs: Biospecimen Procurement and
Translational Pathology (BPTP), Biostatistics and Bioinformatics (BB), Cancer Research Informatics (CRI),
Flow Cytometry and Immune Monitoring (FCIM), Redox Metabolism (RM), with Oncogenomics (OG) and
Patient-Oriented and Population Sciences (POP) as new fully operational facilities in this application resulting
from rigorous SRF management evaluation processes and advisory committee recommendations and
approval. SRFs are led by Dr. Heidi Weiss (TO), Associate Director for Shared Resources; she is assisted by
Dr. Thèrése Bocklage (MCO) Assistant Director for Shared Resources, the SRF Management Office and MCC
Administration. MCC has invested $8.3M in SRF enhancements since 2018. SRF usage is robust, evident by
high numbers of users; SRFs also appropriately prioritize their services, evident by the percent of users from
2018-2022 who are MCC members: BB (156 users, 79%), BPTP (150 users, 61%), CRI (161 users, 65%),
FCIM (87 users, 61%), OG (61 users, 69%), POP (34 users, 71%), and RM (72 users, 68%). MCC Research
Program members heavily utilize SRFs as follows: 84% of Molecular and Cellular Oncology, 85% of
Translational Oncology and 82% of Cancer Prevention and Control. The total number of MCC members using
all SRFs remains consistently high (151 and 171 over MCC’s first two CCSG cycles, respectively). Fiscal
management and business planning from MCC Administration ensure SRF income mechanisms and financial
processes are robust and appropriate. These management strategies and consequent value-added metrics
demonstrate the critical role of SRFs and their direct contributions to MCC’s mission.

Public health relevance
Project Narrative Not applicable. This document is attached to satisfy electronic submission requirements.